Investigation of Sirt1 activation to target IDH mutant glioma

Project Summary
IDH mutant gliomas are incurable, primary brain tumors that affect young to middle-aged adults and are
defined by a mutation in a key metabolic gene. Despite treatment with surgery, radiation and chemotherapy,
these gliomas exhibit unrelenting growth that ultimately leads to neurologic decline and premature death.
Interestingly, many types of tumor cells, including IDH mutant glioma, reprogram metabolic processes to promote
tumor growth. The overarching goal of this proposal is to target tumor-specific metabolic vulnerabilities to more
effectively halt IDH mutant glioma growth. This is based on preliminary data demonstrating that activation of the
critical metabolic regulator Sirt1, using Sirt1 activating compounds (STACs) or Sirt1 overexpression, leads to
cytotoxicity in IDH mutant cells, leading to the hypothesis that IDH mutant glioma sensitivity to Sirt1 activation is
related to IDH-induced metabolic rewiring. This five-year career development project is aimed at investigating
the metabolic underpinnings and effectiveness Sirt1 activation in IDH mutant gliomas using orthotopic mouse
models. This study will also determine the effectiveness of combining metabolic targeting with inhibition of the
cell cycle, a strategy based on the premise that targeting both processes may achieve more effective tumor
eradication. The first aim will test the anti-tumor effectiveness of STACs in combination with cell cycle inhibition
using patient-derived, IDH mutant glioma lines implanted intracerebrally. The second aim will utilize RNA-
sequencing to investigate the cellular processes influenced by STACs. The third aim will explore the ability of
caloric restriction, known to exert longevity-promoting effects through Sirt1 upregulation, to enhance cell cycle
inhibition and prevent glioma growth.
Dr. Miller is a highly trained, passionate physician-scientist uniquely poised to make an impact on
treatment for glioma. She is an Instructor of Neurology at Harvard Medical School in the Pappas Center for
Neuro-Oncology at Massachusetts General Hospital. This K08 application is designed to build on previous
cancer research experience to develop expertise in studying glioma biology. Her mentors, Drs. Cahill and
Wakimoto, are leaders in the field of IDH mutant glioma metabolism and modeling. The proposed project will
also utilize collaborations with established leaders in single-cell transcriptomics and metabolism. This expertise
is complemented by the candidate’s scientific advisors, Dr. Brastianos and Dr. Batchelor, who are experts in
translational Neuro-Oncology. This award will be further supported by the unparalleled institutional support and
environment offered by Massachusetts General Hospital and Harvard Medical School. Dr. Miller’s future goal is
to use the expertise gained during this award to study the effect of novel therapeutics in human patients with
glioma. The K08 is an important stepping stone for building a translational research program in Neuro-Oncology
and ultimately becoming an independent, R01-funded investigator.

Public health relevance
Project Narrative IDH mutant gliomas are slowly progressive primary brain tumors that are diagnosed in young and middle- adulthood and lead to untimely death despite aggressive treatment with surgery, radiation and chemotherapy. We propose to explore how metabolic differences between tumor and healthy tissue can be exploited for use as a treatment strategy in clinically relevant tumor models of IDH mutant glioma. The overarching goal of this research is to determine the effectiveness and mechanism of Sirt1 activation, by small molecules or diet, in preclinical models of IDH mutant glioma to provide a rationale for translating this strategy into human clinical trials.